IGF::OT::IGF Support for Biomedical and Clinical Information Services for the National Library of Medicine and Other NIH Institutes and Centers

The Genetic and Rare Diseases Information Center (GARD) provides information about genetic and rare diseases, available in both Spanish and English, to healthcare professionals and members of the public.